Community Engagement Core

SUMMARY COMMUNITY ENGAGEMENT CORE
As climate change impacts become increasingly visible in the US Caribbean (Puerto Rico [PR] and US Virgin
Islands [USVI]), and adaptation measures move from the planning to the implementation stage, those affected
by climate risks and adaptation strategies cannot be ignored. A fundamental principle of community-engaged
research is to involve people who are most likely to be affected by an issue, as partners in the research process;
where research becomes a tool to be used by communities. The Community Engagement Core (CEC) is
essential as an anchor to the multimethod approach and achievement of the goals proposed by the Caribbean
Climate Change Adaptation, Cancer, and Health Disparities Research Center (CCCARIB-CARES). The CEC will
use a Human-Centered Approach to anchor the collaborative activities that will be designed to involve a range
of stakeholders and community members in both PR and USVI in a Community Coalition of Partners whose
input and assistance will engender effective ways of supporting an increased understanding of climate change
impacts and their linkages to public health issues such as managing cancer and responses to environmental
pollution. It is expected that culturally and linguistically appropriate information and other outputs will be co-
created and applicably disseminated to the diverse and socio-economically challenged communities of PR and
the USVI. The goal will be achieved through the following specific aims: 1) Co-develop and implement a
Community Engagement Plan and establish a Community Coalition of Partners in PR and USVI to collaborate
with project personnel to co-create and disseminate culturally and linguistically appropriate information on cancer
risk factors, cancer control and their linkage to climate change impacts; 2) Develop an inclusive, responsive,
multi-level mechanism to effectively address translation and dissemination of research and CCCARIB-CARES
project findings to the varied audiences of PR and USVI communities and 3) Develop culturally sensitive Toolkits
focused on preparedness for extreme weather events for stakeholders, communities and cancer patients in PR
and USVI. The approach, relationships built and supported, and outputs of the CEC are expected to positively
impact community literacy regarding the linkages between climate change on health and the linkages between
climate change and cancer health. Through the work of the CEC, members of the target communities will be
aware of the resources available to them and can access care and services more effectively. The inclusive and
response approach taken by CEC will support targeted communities aiming to reduce health disparities and to
increase their equity position in society.

Public health relevance
The US Caribbean is vulnerable to natural and environmental hazards and their impact on the cancer control continuum. The Caribbean Cancer Research Center on Environmental and Natural Hazards (CARIB-CARES) will increase capacity at PR and USVI to develop, support, and sustain research, preparedness, and adaptation capacities to help mitigate the impact of natural disasters and environmental pollution on the health of the population, within the context of the cancer prevention and control continuum.